Project 2: Nanobodies as Novel Entry Inhibitors of Pandemic Viruses

Project 2 – Nanobodies as Novel Entry Inhibitors of Pandemic Viruses
Summary
Nanobodies (Nbs) are single domain antibodies derived from camelid heavy chain-only antibodies. Due to
their small size, Nbs have many advantages over conventional antibodies as human therapeutics, such as
their access to cryptic sites on targets, ease of production, superior pharmacokinetics, and strong physical and
chemical stabilities. Nbs also have many advantages over small molecule drugs as human therapeutics, such
as their high on-target specificity and low side effects. Several Nb drugs have been clinically approved to treat
diseases in humans, confirming the safety and efficacy of Nbs as human therapeutics. A novel coronavirus
(CoV) SARS-CoV-2 has caused the global COVID-19 pandemic. The fast emergence of many SARS-CoV-2
variants calls for urgent need of potent and broad-spectrum anti-COVID-19 therapeutics. Compared to small-
molecule antiviral drugs, Nbs are particularly powerful in battling SARS-CoV-2 variants because they can be
quickly adapted to new viral variants through phage display. Moreover, other pathogenic viruses also
demonstrate pandemic potential, such as Ebola filovirus (EBOV), Lassa arenavirus (LASV)/Machupo
arenavirus (MACV), and Zika flavivirus (ZIKV). These RNA viruses all contain a surface glycoprotein that
mediates virus entry into host cells, thus the viral glycoprotein serves as a key therapeutic target. The current
AViDD RFA program specifically includes Nb antiviral drugs as one of its missions. Therefore, Project 2
proposes to develop highly effective Nbs that target conserved epitopes of viral glycoproteins as novel
inhibitors to block viral entry of these pandemic viruses. In our prior studies, we have developed several
potent anti-CoV Nbs, including a series of anti-SARS-CoV-2 Nb candidate drugs named Nanosota-1. We have
established camelid Nb phage display library platforms for Nb screening. We hypothesize that Nbs with high
potency, good stability, low production costs, minimal side effects, superior pharmacokinetics, and broad
antiviral spectrum can be developed as novel antiviral therapeutics. This project has three specific aims. In
Aim 1, we will screen for antiviral Nbs using naïve or immunized Nb phage display libraries. We will also use in
vitro affinity maturation to optimize the target-binding affinity of discovered Nbs. In Aim 2, based on structural
information, we will engineer Nbs to further improve their target-binding affinity and antiviral potency. We will
also improve Nb’s pharmacokinetics and minimize their side effects. In Aim 3, we will test and validate Nb
candidate drugs in animal models against viral infections. This project is built upon a strong research team with
complementary expertise in coronaviruses, filoviruses, arenaviruses, and flaviviruses, solid preliminary data,
well-established platforms, and full support from the administration, chemistry, structural biology, and virology
cores (Cores A and C-E). The overall goals of Project 2 are: (i) to discover Nb therapeutics against SARS-
CoV-2 and its variants, helping ending the COVID-19 pandemic and (ii) to establish Nbs as potent, safe, and
cost-effective therapeutics against other pathogenic viruses with pandemic potential.

Public health relevance
Project 2 – Nanobodies as Novel Entry Inhibitors of Pandemic Viruses Project Narrative In response to this AViDD RFA program, Project 2 proposes to develop nanobody drugs to battle SARS-CoV-2 and its variants, helping ending the COVID-19 global pandemic. It will also establish nanobodies as potent, safe, and cost-effective therapeutics against other pathogenic viruses with pandemic potential such as Ebola filovirus, Lassa/Machupo arenaviruses and Zika flavivirus.